Bmal1, a master regulator of Macrophage cholesterol metabolism

Multiple biochemical, physiological, and behavioral processes are at least partially governed by circadian
rhythms. We have shown that global deficiencies in Clock and Bmal1 increase atherosclerosis. In the past few
years, two studies have published conflicting reports regarding the role of myeloid/macrophage (Mφ) Bmal1 in
atherosclerosis. Therefore, we performed in-depth analyses and observed that Mφ-specific Bmal1 deficiency
increases atherosclerosis in five different mouse models. Our mechanistic studies revealed that Mφ Bmal1
regulates three pathways in cholesterol metabolism. First, Bmal1 regulates uptake of modified lipoproteins by
regulating Cd36 expression. Second, Bmal1 deficiency decreases cholesterol efflux by reducing the expression
of ATP binding cassette subfamily G member 1 (Abcg1). Furthermore, Bmal1 partners with Npas2 to coordinately
regulate Abcg1 via the Zinc finger protein 202 (Znf202) repressor. Third, Bmal1 deficiency impairs cholesterol
egress from lysosomes due to dysregulation of NPC intracellular cholesterol transporter 1 (Npc1) and Npc2 in
Bmal1 deficient Mφs. Based on these findings, we propose three aims to delineate comprehensively the role of
Bmal1 in Mφ cholesterol metabolism.
Aim 1: Circadian regulation of modified lipoprotein uptake. At the molecular level, we will test the hypothesis
that Bmal1 regulates Cd36 by regulating Nuclear Receptor Subfamily 1 Group D Member 1 (Rev-erbα). For
physiologic context, we will extend these studies to Mφ-specific Rev-erbα deficient mice.
Aim 2: Molecular mechanisms controlling cholesterol efflux. We will test the hypothesis that Bmal1
deficiency increases Znf202 expression and that Bmal1:Npas2 heterodimers regulate Znf202. Higher Znf202
levels repress Abcg1 expression through binding to the GnT-box.
Aim 3: Regulation of lysosomal cholesterol egress. We will test the hypothesis that Bmal1 interacts with the
E-boxes in the promoters of Npc1 and Npc2 to regulate their circadian expression and lysosomal cholesterol
egress.
These studies are expected to elucidate key biochemical and molecular mechanisms regulated by Bmal1 that
control modified lipoprotein uptake, cholesterol efflux from Mφs and cholesterol egress from lysosomes, thus
providing comprehensive information regarding Mφ cholesterol homeostasis. These studies should additionally
demonstrate that cholesterol metabolism and circadian regulatory mechanisms are intertwined, and that the
deregulation of circadian pathways alters Mφ cholesterol homeostasis, thereby enhancing the risk of
atherosclerosis. The proposed studies are expected to substantially advance fundamental knowledge in two
fields of biology—chronobiology and cholesterol metabolism.

Public health relevance
Narrative Circadian rhythms control physiology and behavior; disruptions in these regulatory mechanisms predispose individuals to various metabolic diseases, such as atherosclerosis. Hence, understanding the circadian mechanisms that control lipid metabolism at cellular and molecular levels might be useful in developing new methods to prevent and/or treat these diseases. The studies proposed herein should explain how macrophage specific Bmal1 controls circadian regulation of modified lipoprotein uptake, cholesterol efflux and intracellular trafficking of cholesterol.